Population genomic inferences of history and selection across populations and time

Project Summary/Abstract
The growing abundance of population genomic data creates a critical need for inference approaches that can
reveal evolutionary history. The PI's long-term goal is to understand how natural selection shapes the evolution
and function of the molecular networks that comprise life. Toward that goal, the PI's group develops and applies
methods for inferring the evolutionary past from population genomic data. The objectives of this application are to
understand how context affects mutation ﬁtness effects, to develop improved inference methods, and to support
the population genomics research community. The rationale is that this research program will both reveal new
insights into evolution and enhance the ability of colleagues to reveal complementary insights.
The PI's research group has expanded the concept of a distribution of ﬁtness effects to multiple dimensions,
focusing on differences in mutation ﬁtness effects among populations. The PI proposes to apply this approach to
numerous systems, to elucidate the relative roles of genetic and environmental context in creating differences in
ﬁtness effects. The group will also extend this approach to consider differences in ﬁtness effects over time.
The PI developed and maintains the software dadi, among the most popular approaches for ﬁtting population
genomic models to data. The PI will continue to support and enhance dadi, while developing complementary
inference approaches. These will include new diffusion methods based on pairs of loci and the linkage among
them and a novel deep learning approach for inferring the distribution of ﬁtness effects.
The PI helped found the PopSim consortium, which aims to expand the rigor and transparency of population ge-
nomic models for the scientiﬁc community. The PI's group will continue to be active in the consortium, particularly
leading a new initiative to facilitate rigorous testing of population genomic methods via open competition.
The proposed research program is innovative both conceptually and methodologically. The novel concept of a
multidimensional distribution of ﬁtness effects has many applications, and the group will develop novel method-
ology for several population genomics inferences. The expected outcomes of the proposed research are new
insights into the ecology and biology of mutation ﬁtness effects, new population genomic inference tools, and a
framework for blinded evaluation of such tools. These outcomes are expected to have important positive impact
on the ﬁled of population genomics. The methods will be widely applicable and well-supported, and the inferences
will feed into approaches for inferring the evolutionary past and predicting the evolutionary future.

Public health relevance
Project Narrative The proposed research is relevant to public health because understanding natural selection plays a key role in combating genetic and infectious diseases. The proposed research will generate new methods for identifying both negative and positive natural selection in natural populations, including humans. These methods will form a foundation for predicting, for example, rates of adaptation of pathogens and the architecture of human genetic disease.